Role of Intestinal Homeostasis in Organismal Aging

Project Summary
Aging is the major risk factor for Alzheimer’s disease (AD), with changes in the aging
nervous system contributing to AD pathology. The major goal of this proposal is to develop
novel approaches to counteract neuronal aging phenotypes, prolong healthy lifespan and delay
the onset and progression of Alzheimer’s disease. In recent years, loss of intestinal barrier
function has emerged as an evolutionarily conserved pathophysiological hallmark of aging.
Importantly, studies in model organisms, including mice and Drosophila, have revealed that
directly targeting intestinal barrier integrity can mediate healthy lifespan at the organismal level.
However, fundamental questions remain regarding the relationships between intestinal barrier
dysfunction and aging of distal organ systems. Indeed, little is known regarding the causal
relationships between intestinal barrier dysfunction, neuronal aging and AD.
Alterations in the actin filament network have been implicated in Alzheimer’s disease
and related dementias, but the role of neuronal actin dynamics in aging and lifespan
determination has not been characterized. In preliminary work, we have discovered that aging
and age-onset intestinal barrier dysfunction are associated with the accumulation of
filamentous actin (F-actin) and actin-rich rods in aged brains. Furthermore, we have discovered
that targeted, neuron-specific interventions that reduce the hyper stabilization of F-actin in the
aging brain, improve cellular markers of aging and dramatically prolong healthy lifespan. These
findings provide an important first step towards understanding the mechanistic interplay
between neuronal actin dynamics, AD-related neurotoxicity and organismal health during aging.
Here, we propose to build upon these groundbreaking findings by exploring three broad
questions:
1) What are the mechanistic relationships between intestinal barrier dysfunction and
actin dynamics in the aging brain?
2) Can modulating neuronal actin dynamics in aged animals improve neuronal function,
healthy longevity and/or counteract AD pathogenesis?
3) What are the mechanistic relationships between actin dynamics in the aging brain and
other cellular hallmarks of aging; loss of proteostasis and mitochondrial dysfunction?
The work described herein will bring about fundamental knowledge towards our
understanding of the mechanisms of aging and AD-related pathology. Our findings may also
lead to novel therapeutic approaches to counteract aging, AD and related dementias.

Public health relevance
Project Narrative Advanced age is the greatest risk factor for the onset and progression of Alzheimer's disease. We are using the powerful genetics of the fruit fly Drosophila to better understand the biological mechanisms of aging. The long-term goal of this research is to provide novel therapeutic targets to counteract age-related human diseases, including Alzheimer's disease.